Circadian clock disruption: A risk factor for environmental carcinogenesis

Circadian clock disruption: A risk factor for environmental carcinogenesis
Abstract/Summary
Circadian clocks respond to environmental time cues to coordinate 24-hour rhythmicity in gene
expression and biological processes in virtually all cells of the body. According to the US Department of Labor,
~15-20% of Americans are engaged in rotating shift work, and the resulting altered timing of wake/sleep
disrupts their endogenous circadian clock. Epidemiological studies have concluded that individuals who
perform long-term rotating shift work suffer from an increased risk of several cancer types, including skin
cancers. Skin cancer is the most common malignancy and its incidence is increasing dramatically in the U.S.
Among the contributing factors, exposure to solar ultraviolet B (UVB) radiation is the major risk factor (up to
90%) for malignant transformation of skin cells and skin cancer development. In humans and mice, nucleotide
excision repair (NER) removes genetic damage caused by UVB. Therefore, protection from UVB exposure and
ensuring efficient NER capacity are critical for maintenance of genomic stability and prevention of skin cancer.
Previous studies using genetic mouse models have shown that the circadian clock regulates several tumor
suppressing pathways, including NER, that are critical for preserving genomic stability and protection against
environmental carcinogenesis. However, there is a fundamental gap in understanding how circadian disruption
associated with rotating shift work leads to environmental carcinogenesis and in the underlying molecular
mechanisms that influence disease progression in humans. This lack of knowledge is an important roadblock
because it highlights the need for mechanistic insight into malignant transformation and represents a barrier to
predicting the severity of disease outcomes in shift workers. The overall objectives of this project are to identify
and characterize early stage carcinogenesis mechanisms and consequences of circadian disruption in UVB-
induced skin carcinogenesis. Our central hypothesis, supported by preliminary data, is that circadian disruption
undermines DNA repair capacity, inflammatory responses, and other genotoxic stress-related cellular
pathways that underlie the carcinogenicity of shift work. Our studies use circadian synchronized skin cells in
vitro, circadian-disrupted and skin carcinogenesis-prone SKH-1 genetic mouse models in vivo, and skin
samples from human subjects in vivo. In Aim 1, we will determine how the circadian rhythm impacts solar UVB
radiation-mediated DNA damage responses including DNA repair and inflammatory responses. The
experiments described in Aim 2 will examine how clock disruption by rotating shift work influences circadian
rhythmicity and NER. In Aim 3, we will characterize how rotating shift work and genetic disruption of the
circadian clock influence skin cancer initiation and progression. Collectively, the outcomes from these studies
will provide a molecular roadmap of circadian disruption in UVB radiation-mediated genomic instability and
carcinogenesis and will lead to the identification of novel mechanisms that can be applied toward disease
prevention in individuals with abnormal circadian function.

Public health relevance
Project Narrative Disruption of the human circadian clock as a consequence of shift work has negative health outcomes including genotoxic stress, which can lead to cancer. The proposed research will provide a mechanistic understanding of how the circadian clock regulates DNA damage response signaling and how circadian disruption affects genomic stability and environmental carcinogenesis. The proposed work will: 1) ascertain how circadian mechanisms protect against UVB radiation-mediated DNA damage and genomic instability; 2) provide an improved understanding of genomic instability and carcinogenesis outcomes that are associated with circadian disruption; and 3) guide preventive intervention strategies based on knowledge of the mammalian endogenous circadian clock and its regulation of DNA repair processes. The objectives of this project address the NIEHS mission of increasing the understanding of the biological processes that mitigate environmental diseases associated with circadian clock disruption.